New Chemical Tools for the Synthesis of Trisubstituted Hydroxylamines and their Application as Bioisosteres in Medicinal Chemistry

This is a proposal to develop new tools for the practical effective synthesis of N,N,O-
trisubstituted hydroxylamines, or hydroxalogs, as novel isosteres for application in
medicinal chemistry across a broad swath of compound classes and diseases states.
The three specific aims presented encompass i) tools development for the synthesis of
N,N,O-trisubstituted hydroxylamines by a variety of inter- and intramolecular methods; ii)
synthesis of a series of phenylpropylpiperidine ligands for the σ-1 and σ-2 receptors and
their use as models for the comparative study of the physical and drug-like properties of
the hydroxalogs, thereby enhancing their applicability as tools in medicinal chemistry; iii)
synthesis of a series of hydroxalogs of the ethanolamine H1 antagonists and
comparative determination of their antihistamine activity in a cell-based assay, again
with the view to validating the hydroxalogs as isosteres as tools in medicinal chemistry.

Public health relevance
The N,N,O-trisubstituted hydroxylamine moiety, or hydroxalog moiety, is a novel isostere with potential for application in medicinal chemistry across a broad swath of compound classes and diseases states. Development of the hydroxalogs in medicinal chemistry is limited by the paucity of methods for their effective synthesis, particularly by direct N-O bond formation, and by the paucity of data regarding their influence on lipophilicity, and CYP inhibition, as well as stability in liver microsomes, and mutagenicity according to the Ames test. This proposal seeks to develop new tools for the practical synthesis, both inter- and intramolecular, of the hydroxalogs by N-O bond formation and so make them available for broader exploitation by academic and industrial medicinal chemists. The proposal further seeks to validate the hydroxalogs as tools for application in medicinal chemistry by the determination of key physical parameters, stability, and mutagenicity.